Noradrenergic circuits in heights avoidance: an ethological, translatable threat behavior

PROJECT SUMMARY / ABSTRACT
Despite its centrality in anxiety- and trauma-related disorders, the avoidance of danger in the environment
requires new paradigms. Using the RDoC framework, the mental health field has sought to define circuit-
behavior relationships that may underlie psychiatric disorders. A central challenge in this process has been the
difficulty in identify clear links between threat computation and neural circuits. A further threat has been that
even when such links are apparent, as in predator avoidance, the translatability of these behavioral models
across species has been limited. Threat computation plays a central role in the genesis of anxiety- and trauma-
related disorders, yet we do not have a clear behavioral paradigm that enables us to precisely control the
perception of survival danger in the same way in mice and humans.
Here, we propose to develop a novel quantitative circuit neuroscience platform for studying the fear of heights.
Exposure to high places induces common patterns of peripheral arousal, avoidance, and distress across
species yet has been limited in its study in mice. Since physical height is experience through the visual system,
it can be precisely manipulated to induce artificial changes in threat perception that can influence behavior.
Most importantly, the exposure to heights is a stimulus which induces a threat of death across species. Thus,
we propose to establish a controllable model of aversion to visual heights as a new paradigm in the
translational circuit neuroscience of anxiety.
In order to do so, we will combine chemogenetics, fiber photometry, computational modeling of behavior, and a
virtual reality system to demonstrate the role of norepinephrine circuits in the fear of heights. This
comprehensive program is based on substantial preliminary data demonstrating that norepinephrine neurons in
the locus coeruleus are activated by elevation. Furthermore, we will demonstrate the potential of the visual fear
of heights paradigm by manipulating the perceived distance from the ground in real time, thus enabling
unprecedented insights into the online computation of threat that is not possible with other fear-related
paradigms. Once established, this behavioral model will facilitate inference into circuit mechanisms of innate
threat that can for the first time be compared in both mice and humans.

Public health relevance
PROJECT NARRATIVE Our ability to treat anxiety- and trauma-related psychiatric disorders is limited by our ability to precisely control threat computations in a similar way across species. The goal of this project is to develop a translatable, naturalistic model for circuit-behavior linkages using the fear of heights which can be used to understand innate threat across species. Using neurotransmitter biosensors, head-mounted microendoscope calcium imaging, and computational modeling of virtual reality behavior will demonstrate the role of norepinephrine in the aversion to high places.